Biostatistical Support Module

The purpose of the Biostatistics Support Core Module is to support the statistical and
computational needs of core investigators, their collaborators and students, and new investigators
carrying out vision research at the University of Houston. Studies supported by the module will
ranging from basic research to translational and clinical research. The biostatistics module will
provide statistical support via a Core Biostatistician to the ongoing Core investigators, while
facilitating future research and assisting in preparation of new grant proposals from seasoned
investigators and new faculty who are establishing independent research careers. The scope of
support by the BSM will include: study design (sample size and power calculations and writing
statistical analysis plans), plans for data acquisition and/or management, performing statistical
analysis (ranging from short consults to conducting analysis of the research data, including data
management and exploratory analysis). The module also will provide advice on appropriate
software packages and instruction on basic and advanced statistical concepts. A collaboration
with the Texas Institute for Measurement, Evaluation, and Statistics (TIMES), a large statistical
services center at UH will provide access to that institute’s resources. The Core biostatistician
holds a joint research faculty appointment in TIMES to strengthen the Core services by providing
seamless access to additional resources of TIMES, and to strengthen TIMES by adding formally
trained biostatistician to its ranks. The Biostatistics core resources and expertise will stimulate
collaboration and advance vision research at the University of Houston. The module will be
directed by Charles Stewart Professor Ruth Manny OD, PhD with over 40 years of basic,
transitional and clinical research experience, nearly 35 years of NEI funding and 9 years of module
supervision. The Module will be co-directed by Associate Professor Lisa Ostrin, OD, PhD, with
over 12 years of experience conducting basic, translational and clinical vision research.